UCSF Research in Implementation Science for Equity (RISE-2)

ABSTRACT/SUMMARY
Implementation science (ImS) is a branch of research that focuses on the “use of strategies to adopt and
integrate evidence-based health interventions and change practice patterns within specific settings.”1 ImS
holds promise for generating new knowledge to close the gap between what we know can optimize health and
healthcare and what happens in everyday practice, which may be of particular importance for addressing
disparities in health that often result because of failure to deliver evidence-based practice to all populations.
Appropriate training of junior faculty from underrepresented minority (URM) backgrounds in ImS may uniquely
position them to pursue innovative research of interest to the National Heart, Lung, and Blood Institute (NHLBI)
and to launch successful careers as independent investigators. The UCSF Research in Implementation
Science for Equity (RISE) program is an innovative research and career development program grounded in
social cognitive career theory that integrates mentoring and targeted social support with concrete skill building
activities. In particular, RISE has provided didactic training, research experiences, and on-going research
mentoring in ImS for URM junior faculty focused on cardiovascular or pulmonary research, leveraging the
considerable expertise in ImS training at UCSF. These research skill building activities focused on ImS are
paired with an innovative career development program that includes critical activities of importance for this
career stage (including manuscript and grant writing) delivered by successful, NIH-funded investigators who
lead this application and drawing on the broader base of outstanding researchers in cardiovascular and
pulmonary diseases at UCSF. Through this unique combination, RISE has provided 35 URM junior faculty with
tangible methodological and academic skills to enhance their own research and compete successfully for NIH
resources, while also developing a strong network of junior faculty conducting research of relevance to the
NHLBI. The proposed RISE-2 builds on the success of RISE. In RISE-2, the ImS curriculum has been
expanded to include additional case-based skill building in implementation science, as well as the opportunity
to compete for new small research project awards. RISE-2 will also include systematic use of Individual
Development Plans (IDPs) to structure mentoring and scholars’ progress. RISE-2 expands the focus on
nurturing the network of ImS investigators through connecting the proposed 40 new RISE-2 scholars to
established ImS investigators as well as to the robust RISE alumni network, with the latter goal facilitated
through structured teaching, mentoring, and networking activities connecting RISE-2 scholars and RISE
alumni.

Public health relevance
PROJECT NARRATIVE The UCSF Research in Implementation Science for Equity (RISE) program is an innovative research and career development program grounded in social cognitive career theory that integrates mentoring and targeted social support with concrete skill building activities in implementation science (ImS) research. RISE-2 builds on the success of RISE, providing didactic training, research experiences, networking, and on-going research mentoring in ImS for underrepresented minority junior faculty focused on cardiovascular or pulmonary research, leveraging the considerable expertise in ImS training at UCSF. These ImS skill-building activities are paired with an innovative career development program that includes manuscript and grant writing activities delivered by successful, NIH-funded investigators, as well as mentoring and networking with outstanding investigators, including the RISE alumni network.